Institutional Career Development Core

This KL2 is a distinct program with unique elements not found in other institutional K awards at the University, including a focus on individualized training in core competencies, multidisciplinary team science, a variety of disciplines and research experiences, targeted seminars, and an emphasis on the entire spectrum of translational research. Our immediate objectives for the proposed CTS Scholars program are to: recruit outstanding scholars with excellent training in their content areas early in their research careers; train scholars in rigorous research methods to conduct translational research; enhance skills in grant writing, team science, leadership, stakeholder engagement, and entrepreneurship; guide scholars in asking important translational research questions and implementing research projects to answer them; and ensure close mentoring to guide research career development. Our long- term objectives will be to: ensure that Scholars complete their translational research studies on time; help scholars use these studies to propose large-scale projects and obtain independent funding; facilitate scholars' ability to serve as mentors and leaders in translational science; develop resiliency and skills at self-care so that Scholars maintain a successful research career. Our goal is to recruit a pool of Scholars from a variety of training backgrounds, support them throughout their career, and evaluate and track their success over time.